Translational medicine and mechanistic studies of brain neurophysiology in Fragile X Syndrome

Project 1 (P1) investigators have identified cortical EEG phenotypes in humans with Fragile X Syndrome (FXS),
such as enhanced resting state gamma power, that correlate with clinical outcomes. Remarkably, many human
EEG phenotypes are conserved in the mouse model of FXS, the Fmr1 knockout (KO), as discovered by Project
2 (P2) investigators. The across-species conservation of EEG phenotypes strongly suggest similarly
dysfunctional cortical circuits in mice and humans with loss of function of Fmr1. Thus, our proposed studies to
understand and correct circuit dysfunction in the Fmr1 KO mouse will likely be highly relevant to humans with
FXS. We have identified two major functional circuit defects in primary sensory cortex of the Fmr1 KO
mouse that likely contribute to specific EEG phenotypes in Fmr1 KO mice and humans with FXS – 1)
hyperexcitability of “local” circuits within a cortical region and 2) reduced functional excitatory long-
range connections between cortical regions. Hyperexcitability of local circuits is observed ex vivo in brain
slices with 2 key measures: 1) Prolonged Circuit Activation (PCA) of neocortical circuits, either spontaneously or
in response to sensory stimulation and 2) enhanced gamma power. We hypothesize that hyperexcitability of
local neocortical microcircuits underlies the increased resting state gamma power and alterations in
sensory-evoked gamma entrainment of the EEG observed in Fmr1 KO mice and humans with FXS. We
test this hypothesis in mice through mechanistic conservation. Using ex vivo neocortical slices of Fmr1 KO mice
we have discovered 3 synaptic microcircuit changes likely to give rise to hyperexcitable local circuits; 1)
Hyperconnectivity of excitatory synapses between pyramidal neurons 2) Reduced excitatory synaptic drive onto
Parvalbumin-positive (PV) inhibitory neurons 3) enhanced endocannabinoid suppression of inhibitory synaptic
drive – likely from Cholecystokinin-positive (CCK) neurons. In Aims 1 and 2, in close collaboration with P2, we
will use optogenetic, chemogenetic, and pharmacological approaches to manipulate PV and CCK inhibitory
circuits in order to determine how their dysfunction contributes to hyperexcitability of local cortical circuits,
abnormal EEG phenotypes, and related behaviors in Fmr1 KO mice. In addition to hyperexcitable local circuits,
our new findings reveal weak excitatory connectivity between cortical regions in Fmr1 KO mice - specifically
between homotopic contralateral cortical areas (callosal connections). Dysfunctional long-range synaptic
connectivity likely contributes to the abnormal long-range functional coupling between cortical areas as
observed by EEG in humans with FXS). In Aims 3 and 4, we propose experiments to determine the underlying
synaptic and molecular mechanisms as well as the functional circuit level consequences of these weak long-
range excitatory connections. Results of Project 3 (P3) are expected to determine the specific dysfunctional cell-
types, microcircuits, and biochemical mechanisms that likely mediate human relevant EEG phenotypes in FXS
and provide a rationale for specific, targeted therapeutic strategies.
Project Summary/Abstract

Public health relevance
Over the last six years our project teams have demonstrated that neurophysiology abnormalities are conserved across mice and humans in fragile X syndrome (FXS). These findings across species provide a great opportunity to advance mechanistic understanding of clinically relevant illness features and develop translational biomarkers and aid treatment discovery. These advances can bridge the significant chasm between preclinical and clinical success in new treatment development. We take mechanistic approaches to determining the drivers of neurophysiology dysregulation across three integrated projects spanning human, in vivo, and ex vivo mouse study. This allows for levels of analysis from whole brain network modeling to microcircuit and molecular analysis to aid target discovery while improving translational medicine efforts in FXS. In doing this we place emphasis on recognizing heterogeneity within FXS and using this understanding to model how to best interpret and link preclinical and clinical study. Out of this appreciation of the challenges to translational efforts in our field, we have developed a synchronized approach to the analysis and interpretation of neurophysiology data ensuring comparable results across research platforms. The striking consistency of findings across levels of investigation and species offers an unprecedented opportunity to investigate mechanisms of brain dysfunction across mouse and human study thus significantly improving opportunities for translational medicine development in FXS- a multidisciplinary mission that is ideal for a Center environment. Project 1 (Erickson/Sweeney; Cincinnati) will conduct human FXS neurophysiology, behavior, and pharmacological probe studies to pursue advanced neurophysiology modeling of cortical hyperexcitability and abnormal response to stimuli while also seeking to resolve heterogeneity across FXS in humans. Project 2 (Binder/Razak; Riverside) will develop translational neurophysiological biomarkers for FXS in the Fmr1 KO mouse using both surface and depth multi-electrode array technology. Project 3 (Huber/Gibson, UTSW) will investigate the microcircuit and molecular mechanisms of neurophysiologic dysregulation in the Fmr1 KO mouse. All Projects will examine candidate mechanisms of neurophysiologic dysregulation with a pharmacological probe strategy to test mechanisms of interest in parallel studies of mice and patients.